Opioid Treatment and Recovery through a Safe Pain Management Program

PROJECT SUMMARY/ABSTRACT Opioid prescription drug abuse has become a major public health concern in the United States with mortality rates from fatal overdoses reaching epidemic proportions. This opioid crisis coincides with national efforts to improve management of chronic non-cancer pain. The net result, however, has been ever-growing increases in medical expenditures related to prescription costs and increased healthcare service utilization among opioid abusers. Healthcare provider prescribing pattern, especially among non-pain management specialists such as primary care, is a major factor. Louisiana is a major contributor to the epidemic with the 7th highest opioid prescribing rates accompanied by a 12% increase in fatal overdoses. We are overdue for implementing safe opioid management strategies in primary care to combat the opioid crisis. Recent practice guidelines provide recommendations on what to do for safe prescribing of opioids, but they do not provide guidance on how to translate them into practice. We must find ways to accelerate guideline adoption in primary care in the face of an overdose crisis. Health system research that examines a combination workflow- and provider-focused strategies are needed. Given the high prevalence of psychiatric disorders among patients with chronic non-cancer pain, care team expansion with integration of collaborative mental/behavioral health services may be the solution. Collaborative care can extend opioid management beyond standardized monitoring of risk factors for opioid misuse or abuse and set clear protocols for next steps in management. This study is aligned with the National Institute on Drug Abuse’s interest in health systems research that examines approaches to screening, assessment, prevention, diagnosis and treatment for prescription drug abuse. It will examine the primary care practice redesign of managing chronic non-cancer pain within a large health system whose 36 Accountable Care Network-affiliated, adult primary care clinics may serve as an example for transforming opioid management in primary care practices across the country. This four-year stepped wedge cluster randomized control trial is designed to compare the clinical and cost effectiveness of electronic medical record-based clinical decision support guided care versus additional integrated, stepped collaborative care for opioid management of primary care patients with chronic non-cancer pain (clinical pharmacist for medication management; licensed clinical social worker for cognitive behavioral therapy and care coordination); and to examine facilitators and barriers to implementing this multi-component intervention. We anticipate that our study results will elucidate the role of technology versus care team optimization in changing provider opioid prescribing behaviors. We further anticipate that results of our study will demonstrate that integrated mental/behavioral health care for opioid management of chronic non-cancer pain increases value-based care and leads to greater efficiencies in the way that care is delivered.

Public health relevance
PROJECT NARRATIVE This research study is relevant to public health in its potential to: (1) improve clinical outcomes for patients requiring prescription opioid therapy for chronic non-cancer pain; and (2) uncover important considerations for improving value-based care through technology optimization, workflow redesign and behavioral health integration within primary care. Quite simply, optimizing patients' and providers' experiences (e.g. preventing opioid misuse, addiction and overdose while enhancing the functionality of the entire care team) is essential to improve public health in the short- and long-term.